Improving Animal Facility Management and Research Quality

ABSTRACT:
The University of Pittsburgh Division of Laboratory Animal Resources (DLAR) manages 12
separate facilities in 11 buildings. Our current mouse census is in excess of 33,000 cages.
Significant effort is required by husbandry staff for daily cage monitoring including the presence
of food and water, bedding condition, and cage and room temperature and humidity.
During the COVID-19 pandemic, due to staffing issues, DLAR switched from changing mouse
IVC cages every 7 days to every 14 days. The additional 7 days between cage changes caused
an increase in labor to monitor food and water levels and the condition of bedding. Caging
systems that would improve cage and room monitoring represent much-needed improvement and
flexibility to facility management.
This grant seeks funding to provide much needed caging by installing Digital Ventilated Caging
(DVC) and Leddy Lighting System caging from Tecniplast in three holding rooms. These cages
will allow a pilot program to determine their ability to address the issues and concerns described
above. This proposed successful pilot program will provide justification for expanding these
caging systems throughout the vivaria over time.

Public health relevance
NARRATIVE: The proposed R24 application is designed to modernize the animal research facilities at the University of Pittsburgh by purchasing innovative, state-of-the-art caging systems. These caging systems will improve operational efficiency of the animal program and animal welfare by providing up to the minute analyses of environmental conditions in mouse caging. This upgrade will result in animal care staff recognizing potential animal welfare concerns sooner and shortening response times to minimize harmful outcomes.